STUDIES OF PERIODONTAL HEALTH IN ADULT AMERICANS

The periodontal health of employed U.S. adults is being studied in collaboration with university researchers. The collaboration has resulted in several publications and will result in several more. An overall description of periodontal conditions is complete and published. An analysis of the association between sociodemographic variables and periodontal status has also been completed and published. A study developing a model to predict groups at high risk to have periodontal destruction is also complete. Profiles containing sociodemographic characteristics of persons with rapidly progressing periodontitis are being constructed. Distributions of these profiles between different groups of adults are being analyzed.